Fluoroscopic Pulmonary Visualization System To Aid in Peripheral Lung Nodule Diagnosis

Project Abstract Bronchoscopic lung biopsy (BLB) is a critical step in the evaluation of suspected lung cancer. BLB is known to be safe and is the preferred method for lung cancer staging. It is unfortunate, however, that obtaining a definitive diagnosis during BLB remains a significant challenge, as evidenced by the poor diagnostic accuracy of 50-70% when compared to alternative biopsy methods (e.g. CT guided biopsy). The low accuracy is a result of the complex lung anatomy and the inability to visualize the dense, tree-like network of peripheral airways in real time. The ideal solution to this problem would be to directly visualize the airways and nodule intraprocedurally, similar to true image-guided procedures that often require navigation (e.g. vascular angiography). At Pulmera, our ultimate goal is to develop an FDA-approved bronchoscopic device platform consisting of a controller unit and catheter, known as PathFinder, that will significantly improve the diagnostic accuracy of peripheral lung nodule and cancer diagnosis. We are developing a patent-pending device and technique to enable real-time digital fluoroscopic x-ray visualization of the bronchial airway tree and target lung nodule. These real-time airway and nodule images, known as bronchograms and nodulograms, respectively, have a similar appearance to angiograms of blood vessels that use iodinated contrast agents. However, the contrast enhancement that we have developed is accomplished without the use of any potentially-harmful substances and is biocompatible. With this SBIR Phase I proposal, we aim to optimize and test the quality and potential clinical usefulness of our bronchograms and nodulograms in pre-clinical in vivo porcine lung models. A successful outcome of this proposal will be detailed device specifications required to produce consistent, high-quality bronchograms and nodulograms, as well as demonstrate early clinical utility. A future SBIR Phase II proposal would focus on engineering a clinical investigational device prototype from these specifications in anticipation of a first-in-human (FIH) study and initial clinical trial. The results of this Phase I proposal and future Phase II studies will be included in our 510(k) application to the FDA for clearance.

Public health relevance
Project Narrative Lung cancer is the leading cause of cancer-related deaths in the US, and one key to improving patient survival is through earlier diagnosis and treatment. While bronchoscopy plays an integral role in the early diagnosis and staging of lung cancer, well-known limitations exist in its capability to accurately diagnose small peripheral lung nodules and cancers. At Pulmera, we have developed a novel device to enable real-time, image-guided bronchoscopic biopsies, raising the bar on lung cancer diagnosis.